Role of JMJD4 in Pancreatic Cancer

PROJECT SUMMARY – Role of JMJD4 in Pancreatic Cancer
In 2023, nearly 50,000 patients will die from pancreatic cancer in the US. This malignancy has one of
the worst survival rates, indicating the urgent need for better therapies. A more comprehensive
understanding of driving forces in pancreatic cancer may furnish novel ideas how to curtail this disease.
JMJD4 is an enzyme that has been implicated in protein lysine hydroxylation and demethylation.
However, the precise physiological functions of JMJD4 and its mechanisms of action have remained
unresolved. Our preliminary data demonstrate that JMJD4 is upregulated in pancreatic tumors and JMJD4
ablation reduces growth and clonogenicity of human pancreatic cancer cells, while JMJD4 overexpression
may stimulate cell invasion. Further, we provide evidence that JMJD4 interacts with two transcription
factors involved in the development of tumors and chemoresistance: the stress response mediator NRF2
and HIF-2a, a major component of the hypoxia response pathway. This suggests various potential
mechanisms by which JMJD4 could affect pancreatic cancer cells.
Based on these and other preliminary data, we posit that JMJD4 promotes pancreatic tumorigenesis.
Moreover, we hypothesize that JMJD4 functions, at least in part, through modulating NRF2 and HIF-2a.
To test these hypotheses, we propose two specific aims: (i) To determine the role of JMJD4 in pancreatic
cancer cells. (ii) To reveal how JMJD4 acts at the molecular level.
Completion of these studies will greatly advance our mechanistic understanding of JMJD4 and its role
in pancreatic tumors. Furthermore, our research may nominate the JMJD4 enzyme as a novel target for
the treatment of pancreatic cancer. Because JMJD4 is not essential in normal cells, small molecule
inhibitors of JMJD4 are predicted to have minimal side effects, a highly desirable feature. Lastly, insights
gained here likely have implications for the treatment of other diseases, including colorectal and lung
cancer, where JMJD4 is also overexpressed.

Public health relevance
PROJECT NARRATIVE – Role of JMJD4 in Pancreatic Cancer Pancreatic tumors constitute one of the most lethal malignancies, indicating the dire need to develop novel efficacious therapies. Our research will elucidate how the JMJD4 enzyme can facilitate pancreatic tumorigenesis. This may nominate JMJD4 as a potential novel target for therapy in pancreatic cancer.